Molecular Studies of Spinocerebellar Ataxia Type 1

The neurodegenerative proteopathies—a family that includes Huntington disease (HD), Alzheimer
disease (AD), Parkinson disease (PD), and several spinocerebellar ataxias (SCAs)—are etiologically
heterogeneous but share two striking commonalities: 1) each involves the accumulation of a particular disease-
related protein, and 2) although the disease-related proteins are ubiquitously expressed, each disease affects
one brain region or cell type first, and then ramifies to other brain regions. Many groups, including ours, are
studying ways to reduce levels of the relevant disease-related protein, such as huntingtin (in HD), a-synuclein
(in PD), or Ab (in AD). So far, however, regional vulnerability has not been thoroughly investigated, and lack of
understanding of its causes could cause protein-level-reducing treatments to fail.
We learned this through studying SCA1, which is caused by expansion of a CAG repeat in ATAXIN1,
which encodes a polyglutamine (polyQ) tract in the protein ATXN1 (Atxn1 is the mouse version of the protein).
In SCA1, the presenting symptom is ataxia because the first brain region to become dysfunctional is the
cerebellum. Eventually, other regions succumb to the disease, producing cognitive alterations and eventually
death due to brainstem failure. We discovered that lowering Atxn1 levels in SCA1 knock-in mice (Atxn1154Q/+)
improves cerebellar function, but not cognition and that loss of Atxn1 function leads to AD-like hippocampal
degeneration by elevating Bace1 and increasing Ab production. Clearly, then, we need to consider regional or
cell-type vulnerability to avoid relieving pathogenesis in one region while inducing new pathology in another.
We had already learned that the polyQ expansion enhances Atxn1's interactions with the transcriptional
repressor Capicua (Cic), which leads to hyper-repression of Cic target genes. In an SCA1 transgenic mouse
model that expresses expanded human ATXN1 only in Purkinje cells, inserting additional mutations (V591A
and S602D) into the expanded ATXN1 allele to block its interaction with Cic restores motor coordination and
prevents Purkinje cell pathology. In the SCA1 knock-in mice, however, blocking the Atxn1-Cic interaction with
these same mutations only partially improved motor coordination, had no effect on hippocampal deficits, and
only a small effect on survival; these results indicate that either cerebellar cell types besides Purkinje cells or
regions beyond the cerebellum contribute to incoordination (which we will investigate in Aim 1) and that
interactors besides Cic are important in brain regions outside the cerebellum (to be investigated in Aim 2). We
also discovered that increasing levels of Atxn1's paralog, Ataxin1-Like (Atxn1L), which compensates for many
of Atxn1's activities, improves cerebellar function in SCA1 knock-in mice (the groundwork for Aim 3, where we
will investigate the effects of increasing Atxn1L on other brain regions). We propose that understanding
regional vulnerability in SCA1 will enable us to devise approaches to safely treat SCA1.

Public health relevance
Neurodegenerative proteopathies share a common pattern: degeneration starts in one region, and eventually ramifies to other parts of the brain. Spinocerebellar ataxia type 1 (SCA1) is a paradigmatic neurodegenerative proteopathy, and the proposed studies will explore the factors and mechanisms that drive regional brain vulnerability to help us identify the best approaches to safely treat SCA1.